Novel Acquisition and Computation of Cardiac Functions in Developing Zebrafish Embryos

Project Summary
Despite extensive research and medical expenditures, cardiovascular disease continues to be the leading cause
of mortality and morbidity in the modern world. Among animal models used in cardiovascular research, zebrafish
(Dario rerio) has been proven to be the premier model for studies of developmental genetics and functional
genomics owing to their conserved genome, small size, low-cost for maintenance, short generation time, and
optical transparency, just to name a few. Further, zebrafish model enables a forward genetic approach to reveal
the genetic basis and underlying molecular mechanisms of numerous heart diseases. Zebrafish cardiac
physiology shows similar phenotypes to humans and the time-lapse videos of the heart development can be
easily acquired. All these make zebrafish an ideal choice to investigate cardiac development, congenital heart
disease as well as therapeutic potentials.
The embryonic zebrafish (up to ~3 days) are transparent with decent internal organs visibility, including the heart
and the vascular system. Thus, bright field microscopic videos can quantify cardiac mechanism and morphology
at this stage. Conventionally, researchers have to label the ventricle manually, find the End Systolic (ES) and
End Diastolic (ED) frames, and then derive the desired parameters, such as ejection fraction (EF) and heart rate
(HR). This is tedious, time-consuming and inaccurate.
In this context, we aim to develop a Zebrafish Automatic Cardiovascular Assessment System (ZACAS) with
housing chambers, camera chipsets and electronics to give a fast, economic, hassle-free and easy solution for
researchers to assess cardiac functions of developing zebrafish embryos. Specifically, we will i) Develop a novel
apparatus to house and assess developing zebrafish embryos; and ii) Improve our existing framework to work
with real-time videos and ECG taken from the apparatus. The developed system could be an invaluable asset
for thousands of research laboratories worldwide as well as company working on drug screening.

Public health relevance
Project Narrative This Phase I project develops a stand-alone system to acquire and analyze the heart beating videos of embryonic zebrafish, providing cardiac functions in the most accurate, efficient and rapid manner.